Core--Biostatistics

Description: (Applicant's Description) The Biostatistics Shared Resource is a shared resource of the UNMC Eppley Cancer Center. The Biostatistics Core, staffed by the three Ph.D. and 2 MS biostatisticians, supports the research mission of the Cancer Center by providing expertise and assistance in the design, conduct, and reporting of research studies. The facility also provides biostatistical expertise to the Scientific Review Committee and continuing education in the quantitative sciences to Cancer Center members. The facility also includes computing staff to provide system and programming support to the Core, the Protocol Review and Monitoring System, and the Clinical Research Support Shared Resource.